Protein Kinase Signaling in the Genotoxic Stress Response

Project Summary: The long-term goal of our laboratory is to understand how specific protein kinase signaling
pathways function together with phosphoserine/threonine-binding domains and RNA binding proteins (RNA-
BPs) to regulate tumor development after exposure to inflammation and genotoxic stress. We are particularly
interested in understanding how these pathways can be manipulated to enhance cancer prevention, as well as
to improve the response of any tumors that do form to conventional anti-cancer agents. In addition to the two
canonical DNA damage response pathways that cells use to respond to DNA damage, the ATR-Chk1 pathway,
and the ATM-Chk2 pathway, we recently identified a third DNA damage response pathway mediated by
p38MAPK and MAPKAP Kinase-2 (MK2) that is absolutely essential for p53-defective tumor cells to survive
after genotoxic stress. Importantly, the MK2 pathway is dispensable in cells with intact p53 function, making it
an ideal target for specifically impairing the ability of cells undergoing cancer transformation to survive
additional DNA damage. Unlike the ATR-Chk1 and ATM-Chk2 pathways that are dedicated to responding
solely to signals from DNA damage, the p38 MAPK-MK2 pathway is a global stress-response pathway
activated by multiple types of cellular stress, and plays a critical role in cytokine production during inflammation
and early tumor development. Thus, we believe that the p38MAPK-MK2 pathway plays a particularly novel role
during oncogenesis following genotoxic stress by integrating DNA damage response pathways within the
damaged cells with inflammation and cytokine signaling arising in the adjacent stromal microenvironment.
Importantly, both the DNA damage response function, and the cytokine production function of MK2, as well as
many of the activities controlled by ATM-Chk2 and ATR-Chk1, appear to be mediated, in large part, by the
action of RNA-BPs, which control gene expression at the post-transcriptional level. Finally, we and others have
observed that certain xenobiotics appear to cause cell injury and death not through DNA damage, but instead
through a distinct RNA damage response that has been very poorly characterized to date.
In this proposal we (1) investigate the role of MK2 signaling in both the epithelial compartment and the
inflammatory microenvironment in murine models of genotoxic stress-induced cancer development; (2)
elucidate the emerging roles of RNA-binding proteins as key mediators of the cellular response to DNA
damage; and (3) explore a poorly understood RNA damage response that induces profound apoptosis in a
wide variety of epithelial tissues. The flexibility afforded by R-35 mechanism allows us to pursue these
questions using a wide variety of combined experimental and computational approaches. The resulting
mechanistic models are then tested in vivo using murine models of environmental stress-induced cancer and
by querying human patient derived datasets, in order to achieve a transformational impact in the environmental
health sciences.

Public health relevance
Project Narrative Human tumors frequently develop following environmental exposure to toxins and xenobiotics. These compounds result in DNA damage to epithelial cells and induce an inflammatory microenvironment. We believe that the protein kinase MK2, and a subset of critical RNA-binding proteins function as lynchpins connecting inflammation to cancer, and that therapeutic targeting of these molecule will both reduce the incidence of tumor formation in response to environmental/inflammatory stimuli, and dramatically enhance the ability of tumor cells to be killed by conventional anti-cancer agents. We also propose to characterize a poorly understood RNA damage response that is induced by environmental stress.